The University of Arizona Wound Care Center Clinical Research Unit

PROJECT SUMMARY
Approximately 25% of diabetic patients experience diabetic foot ulcers (DFUs). This is a significant clinical
problem since there are no effective biomarkers for predicting outcomes, no drug candidates that have recently
been FDA-approved and no therapies that are widely effective in treatment. Additionally, the prevalence of
diabetes and non-healing DFUs are highest among minorities, such as in Native American and Hispanic
populations, and associated with social deprivation and high mortality.
The University of Arizona (UArizona) is the leading public research university in the American Southwest and an
ideal transdisciplinary research community for studying DFU healing. The partnership between UArizona and
Banner Health provided service to 5,680 patients with open wounds last year. Ranging from trauma to podiatry,
Banner Health saw 3,770 individuals with diabetic foot ulcers (DFUs) in the past 3 years. Dr. Geoffrey Gurtner
has an established history in studying both late-stage biomarker validation through clinical trials and also
mechanistic and early-stage biomarkers identification through the collection of many high-quality biosamples
and longitudinal data (Aim 1). This is supported by both the large patient population at UArizona as well as Dr.
Gurtner’s history in identifying rate cell subpopulations in DFU samples collected from human patients.
Next, we aim to create a unified Standard of Care through the execution of high-quality clinical trials for DFUs,
which historically have been difficult to recruit, and also by collecting high-quality data to address the
heterogeneity of DFUs with complex pathologies, co-morbidities, and social factors. At UArizona, Dr. Gurtner
and Dr. Zhou conduct high-quality clinical trials and have access to a wide distribution of patients and a range of
techniques to make sure that “No DFU Patient Goes Unstudied” (Aim 2). Next, our diverse patient pool will allow
us to specifically understand how social and environmental contextual factors (“social determinants of health”;
SDH) may affect diabetic healing and biomarkers, specifically be recruiting over a diverse and expansive patient
pool (Aim 3). Finally, we have access to not just the entire Banner Health Network (BHN), but also to the Indian
Health Network and outreach programs for Latino communities. Through this expansive network that
incorporates people of all demographics and socio-economic statuses, we will establish effective collaborations
between the CRU and new clinical sites to generate cooperative problem-solving and high-level training, with
shared resources and values (Aim 4).

Public health relevance
PROJECT NARRATIVE At Stanford over the last decade, the Gurtner group has used NIDDK funding to identify the best treatment plans to improve blood flow, decrease blood glucose, and enhance the body's ability to heal wounds and prevent amputations. With Dr. Gurtner recently assuming the position of Chair of Surgery at the University of Arizona (UArizona) College of Medicine-Tucson, the entire team has moved and worked tirelessly to seamlessly transfer all the existing Diabetic Foot Consortium (DFC) studies to UArizona. In this proposal, we will continue these important studies at UArizona to collect a large range of samples from a diverse patient population to improve biomarker identification and standard of care efforts for DFUs, as well as demonstrate our potential for the addition of various satellite sites throughout the Southwest.